Novel oxime antidotes for an organophosphate insecticide requiring bioactivation

7. Abstract
Organophosphate (OP) anticholinesterases, e.g., nerve agents and some insecticides, present a threat to the
civilian population via terrorist activity or accidents. These OP compounds or metabolites are potent and
persistent inhibitors of central and peripheral nervous system acetylcholinesterase (AChE). High dose OP
exposures can lead to seizures, respiratory failure and death. Survivors may suffer from brain damage and
behavioral deficits. One of these OP insecticides, phorate, is very acutely toxic making it a potential threat.
Unlike the nerve agents, phorate requires bioactivation to its anticholinesterase metabolites (oxons) which
results in a delay (4-5 h) in toxic signs (tremors, salivation, and seizure-like behavior). The current therapy (US)
for severe OP poisoning includes atropine plus the oxime AChE reactivator 2-PAM. A major limitation of 2-
PAM is its relatively short plasma half-life and inability to cross the blood-brain barrier (BBB) and protect the
brain. Our laboratories have invented and patented a series of oximes that have shown survival efficacy and
attenuation of seizure-like behavior and neuropathology following exposure of rats to high levels of nerve agent
surrogates and one OP insecticidal metabolite (paraoxon). The delay in toxic signs following phorate challenge
makes the timing of oxime administration and oxime plasma half-life important in establishing an effective
therapeutic regimen. Our lead novel oximes have demonstrated longer plasma half-lives compared to 2-PAM
which should be beneficial combating OPs that have delays in initiation of the cholinergic crisis. Some of our
novel oximes can also effectively reactivate butyrylcholinesterase (BChE) inhibited by the anticholinesterase
metabolites of OPs including phorate. BChE is prominent in serum and is inhibited by circulating oxons. An
oxime that can effectively reactivate BChE, creating a pseudo-catalytic bio-scavenger of circulating oxons,
could prevent or attenuate OP-induced toxicity. The Aims of this project are: 1) Characterize the temporal
relationship between ChE inhibition and the phorate toxidrome, and the survival efficacy provided by 3
novel oximes; 2) Demonstrate in vitro (rat and human) and in vivo (male and female rats) with a down-
selected lead novel oxime the ability to reactivate phorate inhibited BChE and enhance survival. The
challenge dosage of phorate will be lethal (LD99) to rats receiving atropine only. A novel oxime or 2-PAM will
be administered at the initiation of seizure-like behavior and at one earlier time point prior to initiation of
cholinergic crisis. In addition, oxime-mediated reactivation of OP-inhibited BChE will allow a demonstration that
pseudo-catalytic BChE-mediated destruction of OP can attenuate toxicity. A selective BChE inhibitor will be
used to confirm the significance of BChE reactivation, as evidenced by a reduction of AChE inhibition and
lethality in oxime-treated rats having functional BChE (rats not receiving the BChE inhibitor). The data from this
translational project will be used to further develop an oxime into a more effective therapeutic for poisoning by
insecticidal OPs, like phorate, that display a delayed toxidrome because they require bioactivation.

Public health relevance
8. Project Narrative The organophosphate (OP) insecticide phorate must be bioactivated to an active metabolite(s) and thus it takes several hours to display toxic signs. Some of our novel oximes have appreciably longer half-lives (several hours) than 2-PAM (about an hour) and they also can reactivate OP-inhibited plasma butyrylcholinesterase, potentially converting it to a pseudo-catalytic scavenger. In this project we expect our oximes to provide greater survival efficacy of lethal doses of phorate than 2-PAM because of their longer plasma presence and their prolonged conversion of plasma butyrylcholinesterase into a pseudo-catalytic detoxication mechanism.